Administrative Core

Summary
The overall mission of the San Diego Digestive Diseases Research Center (SDDRC) is to foster basic,
translational and clinical research to improve the prevention and treatment of inflammatory diseases of the liver
and digestive tract. The SDDRC provides a range of technical services to the research labs of its members
drawn from three preeminent academic institutions in the San Diego, and supports pilot/feasibility and
enrichment programs. To achieve its mission, the Center is supported by an Administrative Core for the
effective overall management, smooth coordination and diligent supervision of the diverse Center activities. The
Administrative Core, mandated by NIH guidelines, plays an indispensable role in ensuring the success of the
Center and its members by performing the following functions: a) Coordination of center components and
staffing, b) Membership determination and privileges, c) Organization of Executive and Advisory Committees, d)
Administration of Pilot/Feasibility Program, e) Organization of Enrichment Program events, f) Fiscal oversight,
g) Record keeping, h) Dispute resolution, i) Communication with Center membership, j) Maintenance of Center
website, and k) Interactions with other Cores, Centers and NIDDK. The Center and Administrative Core are led
by two experienced Co-Directors, Dr. Bernd Schnabl and Dr. Lars Eckmann. The routine administrative functions
of the Core are executed by a dedicated full-time Center coordinator with the support of an administrative
assistant. The Center Co-Directors are supported by an Executive Committee that includes the Directors and
Co-Directors of the three Biomedical Research Cores. An Internal Advisory Board, comprised of two Center
members from the consortium of Center-participating institutions and two experienced faculty from outside of the
Center, provides advice and oversight. An External Advisory Board gives broader context to overall Center
operations by meeting annually with the Center leadership to review progress and make recommendations on
Center activities and pilot/feasibility grant applications. A Community Advocacy Board raises awareness about
the needs of patients with diseases of the digestive tract. Support from a Silvio O. Conte Digestive Diseases
Research Core Center P30 award for an Administrative Core is critically important for the SDDRC to achieve its
missions of promoting research to improve digestive health and lessen the burden of digestive diseases.